Patient-Centered Informatics for Chronic Pain Management

Background: Opioid prescriptions for chronic pain are a major contributor towards the ongoing opioid
epidemic, adding to a record high number of drug overdose deaths in 2022. Shared decision-making between
patients and providers is highly valuable to align the array of treatment options and non-pharmacologic
treatments (NPTs) with Veterans’ unique pain experiences. Newer data streams, including patient-generated
health data (PGHD) that are created directly by patients, offer rich information not typically assessed during
visits (e.g., patient-reported outcomes, pain functioning, physical activity). This CDA-2 aims to enhance pain
management by building a shared decision-making tool that collects pain PGHD and harmonizes it with
treatment preferences and medications to improve use of NPTs and reduce pain interference and opioid use.
Significance/Impact: The opioid crisis is salient for VA, as up to 50% of Veterans (over 2 million) experience
chronic pain. There is a critical need to improve pain management and reduce opioid use among Veterans with
chronic pain. This research seeks to address these challenges by developing and testing a tool that facilitates
shared decision-making and adoption of NPTs. Further, building interoperable clinical informatics tools that can
be scaled across the VA will advance the VA’s ongoing electronic health record (EHR) modernization efforts.
Innovation: This proposal will improve pain management through three innovations: 1) identification of the
content, visualizations, and clinical integration factors needed to support patient-clinician collaboration around
pain PGHD, 2) development of an interoperable clinical decision support (CDS) tool that visualizes PGHD and
EHR data at the point-of-care, entitled Patient-generated Assessment Technology for improved Health
(“PATH for Pain Management”) and 3) identification and characterization of Veterans’ pain treatment
preferences and goals through natural language processing methods.
Specific Aims: 1) Aim 1: Gather insights from Veterans with chronic pain on preferences for reporting their
pain experience and goals. Aim 1a: Examine Veterans’ perspectives on sharing pain-related PGHD with
clinicians and preferred pain measures to communicate their pain experience; Aim 1b: Identify and describe
pain treatment preferences and goals from clinical progress notes. 2) Aim 2: Iteratively design and develop the
PATH for Pain Management CDS tool that incorporates pain PGHD and facilitates shared decision-making to
improve chronic pain management. Aim 2a: Design the structure and content for a CDS tool that presents
information about a Veteran’s pain experience through interviews with VA pain providers; Aim 2b: Develop a
web-based prototype of the tool using the VA’s CDS Program Platform. 3) Aim 3. Conduct a comprehensive
usability evaluation to optimize the acceptability and use of the PATH for Pain Management CDS tool that
promotes shared decision-making for Veterans with chronic pain.
Methodology: In Aim 1a, human-centered design methods will identify Veterans’ preferences for pain
measures to communicate with their care team. In Aim 1b, natural language processing will be used to identify
and describe treatment preferences and goals among Veterans seen at three multidisciplinary pain clinics. In
Aim 2a, interviews will be used to examine VA pain providers’ preferences for the content and visualizations of
the CDS tool. In Aim 2b, we will develop a functional prototype based on the feedback from Veterans and
providers. In Aim 3, usability and feasibility of clinical integration of the tool will be assessed among providers.
Next Steps/Implementation: These findings will inform development of two HSR&D investigator-initiated
research (IIR) proposals to be submitted in years 3 and 5, which focus on implementing these novel tools into
VA care and evaluating patient outcomes. Notably, this approach can inform future development and
implementation of clinical informatics tools that integrate PGHD into VA care for chronic disease management .

Public health relevance
With up to 50% of Veterans experiencing chronic pain, there is a critical need to improve pain management amidst the ongoing opioid epidemic. Substantial progress has been made in reducing opioid use and improving pain management, yet there is limited information to assess treatment progress or pain levels outside of infrequent clinic visits. The recent proliferation of patient-generated health data (PGHD) from mobile apps, personal health records, and wearable devices have potential to transform pain care by integrating patient- reported outcomes and lifestyle data into care. This CDA-2 will develop a novel patient-centered clinical decision support tool that collects and visualizes pain PGHD to facilitate shared decision-making and treatment opportunities. This work leverages strong engagement from Veterans, clinicians, and operational partners. The findings and tool may be applied to other chronic diseases to integrate emerging data streams into VA care.